Development of a quasi-ideal photon counting x-ray detector with spectral coincidence counters

Project Summary
The proposed project aims at developing the next generation of photon counting detectors (PCDs) with multi-
energy inter-pixel coincidence counter (MEICC) and digital pulse energy correction (DPEC) for x-ray computed
tomography (CT). We believe that MEICC–DPEC design will bring PCDs much closer to ideal devices and
brings many clinical dreams surrounding PCD CT into reality. In a prior R21 EB029739 grant, we developed
MEICC concept using Monte Carlo simulations and found that MEICC improved the dose efficiency by a factor
of 3.9, which is 87% (=3.9/4.5 with respect to dose efficiency) toward the ideal spectral PCD. Simulations
showed that DPEC made the PCD performance almost insensitive to the intensity of x-rays. Building upon this
foundation, under this BPI project, we propose to translate our theoretical results into the real world, fabricate
physical application-specific integrated circuits (ASICs) with MEICC–DPEC functionality, develop algorithms to
process MEICC–DPEC data, and evaluate the performance of PCD using a tabletop x-ray CT system. Our
goas are to achieve Cramér–Rao lower bound values (i.e., the minimum noise variance with unbiased
estimators) that are >75% lower than the current PCD with 2 energy bins for spectral imaging tasks, which
corresponds to dose efficiency improvements by a factor of >4. The specific aims are: (SA1) Optimize MEICC–
DPEC design parameters and develop algorithms. (SA2) Develop MEICC–DPEC PCD. (SA3) Assess MEICC–
DPEC PCD using a tabletop CT system. We will compare results against (a) the same PCDs but with 2 energy
bins without MEICC–DPEC, (b) a clinical PCD CT system, and (c) two clinical dual-energy CT systems.
Experimental results in SA3 will be compared against computer simulation results in SA1.

Public health relevance
Project Narrative We propose a technical solution that enables nearly ideal photon counting detectors (PCDs) for x-ray computed tomography (CT), which will bring most of clinical dreams surrounding PCD CT into reality.